PERIPHERAL NOREPINEPHRINE STORE IN PHEOCHROMOCYTOMA

540 The ratio of plasma dehydroxyphenyl glycol to norepinephrine (NE) levels will indicate whether or not exagerated neuronal release of NE occurs in patients with pheochromocytoma.